Leadership and Administrative Core

Project Summary/Abstract – Leadership and Administrative Core
The Deep South Resource Center for Minority Aging Research (RCMAR) is designed to enhance the size of the scientific workforce advancing the fields of aging and health disparities research. We are a research-based, mentoring partnership of four academic institutions, The University of Alabama at Birmingham (UAB); The University of Alabama (UA); Morehouse School of Medicine (MSM), and Tuskegee University (TU) working together to recruit junior faculty investigators provide education in aging and health disparities research, guide career development through collaborative mentoring, and sustain progress to successful, independent research careers. The Leadership and Administrative Core (LAC) will provide intellectual leadership and administrative oversight for the Deep South RCMAR. The specific aims of the LAC are to: (1) ensure the integration and coordination of all Deep South RCMAR activities, (2) provide oversight and support for the recruitment and selection of RCMAR Scientists, (3) facilitate collaborative mentoring and research activities with complementary programs, and (4) provide administrative oversight for all programs. Integration and coordination of activities will be accomplished through effective interactions, communication, and information flow externally and among investigators and Scientists across the Research Education Component (REC), the Community Liaison and Recruitment Core (CLRC), and the Analysis Core (AnC), as well as among the four partnering academic institutions, and with other RCMARs, the Coordinating Center, related research centers, and the National Institute on Aging. The LAC will work closely with the other cores and leadership of the partnering institutions to identify and recruit promising researchers, establish mentorship teams tailored to each Scientist’s needs, and promote collaborations with complementary programs to support REC activities and leverage resources in support of RCMAR Scientists. The LAC will maintain an External Advisory Committee composed of a Community Advisory Group, a Professional Advisory Group, and a RCMAR Scientist Alumni Group, to provide feedback ensuring that the activities of the cores are relevant both to the development of RCMAR Scientists and the research focus of improving health outcomes among older adults in the Deep South. With this renewal application, we propose to continue and enhance the activities of the LAC in serving the goals of our RCMAR and its enduring commitment to mentoring junior faculty investigators focused on aging and health disparities research among older adults in the Deep South during the next funding cycle.